Muscular Dystrophy Specialized Research Center

Core B Summary
The Muscle Tissue/Cell Culture/Diagnostics Core of the Iowa Wellstone Muscular Dystrophy Cooperative
Research Center is a multifaceted laboratory that serves as a local, national and international resource for
research on muscular dystrophy and other neuromuscular diseases. This Core has two major goals. Firstly, it
has established and will expand a tissue and cell culture Repository to support basic and translational research
efforts. Currently, this Repository contains muscle biopsies from nearly 9000 patients with neuromuscular
disorders, as well as cryopreserved fibroblasts from more than 450 patients with myopathic disease,
predominantly muscular dystrophies. Well-characterized tissues and cells from the Core are made available to
research investigators at Iowa as well as other academic centers across the USA and around the world.
Secondly, the Core provides specialty diagnostic services that are not readily available through clinical
laboratories and facilitates research on and the development of new diagnostic tests for eventual transfer into
clinical laboratories. These diagnostic services are very closely integrated with clinical laboratory testing
carried out in the Department of Pathology at the University of Iowa. Together, Core B and the Department of
Pathology services provide state-of-the-art diagnostic testing for patients seen at the University of Iowa
Hospitals and Clinics, and for patients referred to Iowa from throughout the USA and from several other
countries. This infrastructure provides key support for clinical trials of neuromuscular disease.